Using Multimodal Data Science To Gain Actionable Insights For Substance Misuse Prevention

Substance misuse, encompassing opioid misuse, non-opioid illicit use, and alcohol misuse, constitutes a
heterogeneous set of conditions associated with high mortality and is a primary driver of rehospitalizations.
Despite efforts to reduce harm through tertiary prevention strategies centered on fatal events, the substance
misuse epidemic has continued to escalate. Recently, we constructed the Substance Misuse Data Commons
(SMDC), a first-of-its-kind data platform that captures early warning signs - emergency department visits and
hospitalizations - that lie on the path to fatality and that the National Drug Control Policy recommends using to
improve tertiary prevention efforts. The SMDC integrates structured and unstructured longitudinal data from
electronic health records, social disadvantage, medical and pharmacy claims, criminal justice, and health
surveillance data to provide a comprehensive picture of regional substance misuse.
The goal of this proposal is to utilize the SMDC and stakeholder engagement to develop an equitable
multimodal artificial intelligence (AI) model to predict outcomes for substance misuse patients. In Aim 1, we will
derive a multimodal AI model for predicting all-cause death or rehospitalization post-discharge and externally
validate it on urban and rural cohorts. In Aim 2, we will use statistical algorithms to ensure that the model usage
will lead to equitable treatment for all patients. Both aims will be accomplished using iterative feedback from a
stakeholder group comprised of former patients, emergency providers, and addiction specialists. Completion of
this proposal will lead to an accurate, equitable, and feedback-driven AI prognostication model for integration
into clinical decision support for substance misuse.

Public health relevance
This proposal leverages the Substance Misuse Data Commons, which combines rural and urban hospital data, public health agency data, and insurance claims data, to develop an accurate, statistically fair, patient- and clinician-stakeholder-driven multimodal artificial intelligence (AI) prognostication model to predict outcomes for patients with substance misuse. We anticipate that the research will provide a comprehensive picture of regional substance misuse, enable the integration of AI models into clinical decision support for health systems, and aid clinicians, state health departments, and public safety in their tertiary prevention efforts against substance misuse to reduce future hospitalizations and deaths. The proposed research is relevant to NIH’s mission to leverage data science for actionable insights into tertiary prevention strategies to improve health outcomes in substance misuse.